Comprehensive CT Guided Coronary Artery Bypass Graft Surgery

Project Summary

Coronary bypass graft surgery (CABG) improves the lives of patients with coronary disease (CAD) as a group,
but 20% of patients remain symptomatic one year after surgery. In clinical practice CABG decisions are largely
driven by stenosis severity determined from invasive angiography despite the known relevance of functional
CAD parameters. This practical impasse will continue to exist without clinically available, high-­resolution,
quantitative functional imaging, and a better understanding of the clinical outcomes in relation to anatomical
(angiography) and functional (ischemia, scar tissue) factors. The long-­term goal is to improve outcome of
CABG through personalized imaging-­guided care. The overall objective of this proposal is to identify
determinants of myocardial flow restoration (ischemia reduction), and develop integrated imaging tools for
individualized, lesion-­specific CABG decision-­making, and computational flow simulations based on the
patient’s anatomy and function to predict the hemodynamic outcome. Supported by studies using invasive
FFR-­guided CABG, the rationale for the proposed research is that integration of anatomical (angiography)
and functional information (ischemia, scar tissue) will identify individual coronary vessels that will benefit from
revascularization, and individual optimization of surgical procedures by flow simulations will maximize clinical
benefit of CABG for patients with CAD. Supported by promising preliminary data, three specific aims are
proposed: 1) Prospectively identify angiographic, functional and clinical baseline determinants of outcome
after CABG, defined as improvement of myocardial perfusion (ischemia reduction) and angina symptoms;; 2)
Develop and validate a comprehensive imaging strategy and clinically applicable tool that integrate high-­
resolution angiographic and quantitative functional information (ischemia, viability) for per-­vessel/lesion
revascularization decisions;; 3) Develop and validate new multi-­parametric computational flow simulations,
with incorporation of functional imaging data, which allows for prediction of individual hemodynamic outcome
and ultimately surgical optimization based on virtual hemodynamic results. This approach is innovative
because new imaging techniques will advance the field’s understanding of CABG physiology, and new
clinically applicable tools will be developed for comprehensive clinical decision-­making and optimized surgical
planning. The acquired knowledge and developed tools are applicable to other vascular contexts, and may
also be instrumental for new therapeutic innovations. The proposed research is significant because
identification of CABG outcome determinants, and new solutions for comprehensive decision-­making and
procedural guidance, have the potential to improve the effectiveness (by complete functional
revascularization) and efficiency of CABG (by avoiding futile grafts). For a large group of patients, these
innovations will improve the patient-­valued benefit of CABG (complications, symptoms), and also decrease
cost by improved efficiency of care.

Public health relevance
Project Narrative The proposed research is relevant to the public health because identification of CABG outcome determinants, and development of diagnostic solutions for comprehensive decision- making and procedural guidance of CABG surgery, can help achieve complete functional revascularization and restoration of myocardial blood flow in more patients. Thus, the proposed research is relevant to the NIH’s mission that pertains to the discovery of fundamental knowledge about the nature and behavior of living systems and the application of that knowledge to enhance health, lengthen life, and reduce illness and disability.